Mechanisms of Adventurous-motility in Myxococcus xanthus

Embryonic development of vertebrates requires coordinated multicellular movements, but little is known about how such movements are regulated. Vertebrates are not easily subjected to intrusive experimental manipulations, so a simpler organism that displays similar behavior is better suited for this type of study. The bacterium Myxococcus xanthus serves as an ideal organism for studying multi- cellular movements, as M. xanthus cells move as communal swarms by gliding and assemble into complex multi-cellular fruiting bodies, followed by differentiation of myxospoes when nutrients are limited. Gliding motility in M. xanthus is controlled by two independent genetic systems: Adventurous (A) and Social (S). The S-system provides movement for cells in close proximity and depends on type IV pili. The A-system provides motility for isolated cells, but the mechanism remains unclear. The main goal of this proposal is to understand mechanism of A-motility by identifying the A-genes. The correlation between A- motility by identifying the A-genes. The correlation between A-motility and elasticotaxis, and coordination of the two independent motility systems in M. xanthus will also be investigated.